Elucidating the Pathophysiology of Gestational Diabetes Mellitus

PROJECT SUMMARY/ABSTRACT
Dr. Egan is a physician trained in clinical endocrinology and will undertake a four-year mentored research and
career development program in the pathophysiology of gestational diabetes mellitus (GDM) at Mayo Clinic. She
will complete a master’s degree in Clinical and Translational Science, gain experience in the conduct of in vivo
studies in an obstetric population, acquire new skills in analysis and modeling of human physiological data, and
develop scientific leadership skills and collaborative relationships. These activities will fill current gaps in
knowledge and allow Dr. Egan to become an independent clinical investigator. Dr. Egan will be guided by a team
of prominent researchers with relevant areas of expertise and an excellent track record in mentoring young
faculty. This team will be led by her primary mentor, Dr Adrian Vella, whose research focuses on the
pathogenesis of type 2 diabetes mellitus (T2DM). GDM is a common pregnancy complication and while the
associated hyperglycemia resolves postpartum, it is a strong risk factor for T2DM. There is little understanding
of maternal β-cell function in early pregnancy, how this may predict GDM in later pregnancy, and what changes
occur postpartum. Dr. Egan’s preliminary data suggest that α-cell function also changes during pregnancy, but
its role in GDM development and postpartum glucose tolerance is unknown. In the proposed in vivo studies, Dr.
Egan will determine the degree of β-cell (Aim 1) and α-cell (Aim 2) dysfunction needed to produce GDM and
examine the islet cell recovery (or lack thereof) that occurs postpartum. Dr. Egan will assess if GDM can be
predicted earlier in pregnancy which would facilitate more timely intervention. She will also identify the residual
defects in glucose metabolism that persist at one year postpartum. Such defects could contribute to the
accelerated progression to T2DM observed in women with GDM (Aim 3). To accomplish these aims, Dr. Egan
will study women during pregnancy and post-partum using state-of-the-art, non-invasive techniques to collect
and examine detailed physiologic data. In keeping with the NIDDK mission, the proposed studies will address
important aspects of diabetes development in women and provide the foundation for a future R01 application
with the goal of developing novel diabetes prevention and treatment approaches.

Public health relevance
PROJECT NARRATIVE Gestational diabetes mellitus (GDM) is the most common metabolic complication of pregnancy and is associated with an increased risk of adverse pregnancy outcomes and future type 2 diabetes mellitus (T2DM). The proposed studies will examine how human endocrine pancreatic function changes during and after pregnancy, and how women with and without GDM differ in terms of their glycemic control. The proposed work may identify pathways leading to GDM and postpartum T2DM which can be targeted in novel prevention and treatment strategies.